Participatory Action Research for Change: Collaborating with FSM youth to develop a multilevel intervention approach to HIV/STI prevention in Guam

Project Summary/Abstract
People from the Federated States of Micronesia (FSM) who move to Guam suffer disproportionately poor health
outcomes, including high rates of HIV and STIs. However, most STIs are identified during prenatal care; thus,
data are unreliable and likely underestimate actual community prevalence. This is particularly true for
adolescents and young adults (AYA), aged 15-24, who are even less likely to seek care. Previous research
determined that barriers to seeking HIV and STI prevention, testing, and treatment include stigma – both
community-based and that imposed by outside actors; inequitable sexual relationships, and a lack of bodily
autonomy; poverty, work and family obligations; limited ability to navigate the healthcare system; transportation
access; and medical racism and bureaucratic disentitlement within Guam’s public healthcare system. All of these
factors are mediated by the community tensions fostered by U.S. management of immigration in Guam.
Micronesian communities have historically participated in shared decision-making models for community
solutions. Participatory Action Research (PAR) is a model that works in such communities; it recognizes
community participants not just as givers of knowledge, but as producers and partners in the development of
research questions, designs, distribution, and dissemination, and compliments already-established models of
community decision-making. In collaboration with two advocacy groups who recognize these barriers to care:
Neechuumeres: Chuukese Women’s Group of Guam and FSM Association, the purpose of this exploratory study
is to collaboratively identify factors that influence HIV and STI prevention and treatment among FSM diaspora
AYA, and design an intervention using a PAR approach. Engaging with the theory of structural vulnerability, this
4-year, theory-engaged, community-driven mixed-methods research-to-action project has the following specific
aims: (1): Develop a community-based research partnership; train partners; conduct formative research on
individual, community, and structural factors that shape HIV and STI prevention, testing, and treatment in FSM
diaspora youth of Guam; (2): Collectively develop a multi-level theory-informed intervention to address these
factors; and (3): Test and evaluate the intervention, and adapt it for expansion. This study will be the first of its
kind to examine determinants and correlates of HIV and STI prevention through community-centered research
in action-oriented migrant-focused organizations in the U.S. territory of Guam, where resources are limited due
to its territorial status. It will address an important health inequity issue in a Guam community using a theory-
based, mixed-methods collaborative approach, and lead to a community-centered intervention design. In
accordance with R16 SURE first grants, the PI will use the support to develop an extramurally funded research
program at SUNY Old Westbury that involves undergraduate students, and use the findings to prepare an R21
to expand and test the intervention at a larger scale.

Public health relevance
Project Narrative Adolescents and young adults (AYA, aged 15-24) from the Federated States of Micronesia (FSM) living in the U.S. Territory of Guam suffer disproportionately high STI incidence rates and are at high risk for HIV transmission. Utilizing the theory of structural vulnerability and a participatory action research approach, the purpose of this exploratory study is to collaboratively identify and address factors that influence HIV and STI prevention, testing, and treatment in FSM diaspora AYA communities of Guam with two migrant-centered community organizations and the youth impacted. Findings from the intervention will be used to adapt and expand the reach, to further improve HIV and STI prevention, testing, and treatment in this community.